Neural Mechanisms of Stereoscopic Vision

Project Summary/Abstract
Stereopsis is the perceptual process in which the brain combines and compares the input from the two eyes
to reconstruct the three-dimensional visual world. Despite the importance of stereoscopic vision in healthy and
diseased conditions, its underlying circuit mechanisms remains poorly understood. Here, tree shrews are used
as an animal model for stereopsis research. The tree shrew offers many advantages, such as a highly developed
visual system, primate-level selectivity for binocular disparity, and a short reproductive cycle that allows for
developmental studies. In Aim 1, the investigators will reveal the spatial organization of disparity selectivity in
tree shrew primary visual cortex (V1). Two-photon Ca2+ imaging will be performed to determine the orientation
maps in V1 and the disparity selectivity of individual neurons in response to random dot stereograms and
dichoptic sinusoidal gratings. Multi-channel electrophysiological recordings will also be conducted and guided
by the imaged maps. These experiments will reveal the relationship between disparity tuning and orientation
selectivity and the spatial profile of disparity selectivity across layers and cortical maps. Aim 2 will test the
hypothesis that inhibitory neurons in tree shrew V1 are sharply tuned to disparity, thereby mediating the
orientation-specific recurrent inhibition. This is done by 2-photon Ca2+ imaging using cell type specific viral
expression of Ca2+ indicators in inhibitory neurons, and their subtype identity is then revealed ex vivo using
fluorescent in situ hybridization. The activity pattern, response dynamics, and disparity tuning of these neurons
will be determined. Parallel experiments will be performed in mice using transgenic lines that label specific
subtypes of inhibitory neurons. These experiments will reveal whether subtypes of inhibitory neurons show
distinct tuning properties to binocular disparity and whether these properties differ between species. Aim 3 will
determine the synaptic connectivity of disparity selective neurons in tree shrew and mouse V1, by dendritic
imaging in both excitatory and inhibitory neurons. The experimental results in all aims will then guide the
implementation of a biologically realistic network model for disparity selectivity, which will then make testable
predictions for subsequent experiments. Together, by comparing two species that have different cortical
architecture and disparity selectivity, and by combining in vivo experiments and computational modeling, these
studies will reveal general principles of stereoscopic vision. Because stereopsis is disrupted in people suffering
from amblyopia and strabismus, this project will provide novel insights into the understanding and treatment of
these disorders.

Public health relevance
Project Narrative A long-term goal of our research is to reveal the function and development of precise connections between neurons in the nervous system. These studies are of great clinical importance, because many neurological and psychiatric disorders result from miswiring of synaptic connections during development, such as amblyopia, strabismus, cortical blindness, and autism spectrum disorders. Our studies will contribute to the understanding and treatment of these diseases.